AZT THERAPY FOR PATIENTS WITH EARLY AIDS-RELATED COMPLEX

This is a randomized, placebo-controlled study to evaluate the safety, effectiveness and toxicity of azidothymidine (AZT) when given to individuals with early symptoms of AIDS-related complex.